Molecular Cytogenetic

PROJECT SUMMARY (See instructions): The Molecular Cytogenetic Shared Resource (MCSR) provides tools for the preparation of human and murine samples suitable for molecular genetic and cytogenetic analysis of the entire genome. The goal is to provide Cancer Center investigators with the whole spectrum of services necessary to analyze the genome at various levels of resolution. These services include the establishment of EBV transformed cell lines and isolation of DNA and mRNA from a variety of tissue culture samples as well as primary biopsies. The facility operates in conjunction with the Genomics Shared Resource to create a direct pipeline for the provision of genomic material for analysis. A full panel of services is provided, from preparation of metaphase chromosomes to the generation of custom designed probes and hybridization for the detection of copy number and structural chromosomal alterations. The MCSR provides analyses at all cytogenetic levels of resolution from standard to spectral karyotyping and from whole chromosome paints to locus-specific probes for unique regions of the genome. MCSR personnel are trained to design targeted, locus-specific probes for regions of interest to investigators. All probes are custom designed and generated in-house. The MCSR also performs hybridizations on paraffin-embedded tissues as well as image acquisition and full data analysis.

Public health relevance
RELEVANCE (See instructions): The Molecular Cytogenetic Shared Resource provides tools for the preparation of human and murine samples suitable for molecular genetic and cytogenetic analysis of the entire genome that support the translational research mission and goals of the Albert Einstein Cancer Center (AECC). As an NCI designated Cancer Center, AECC contributes to the national effort to reduce morbidity and mortality from cancer.